SBIR TOPIC 417: QUANTITATIVE IMAGING SOFTWARE TOOLS FOR CANCER DIAGNOSIS AND TREATMENT PLANNING

With brain metastases (BMs) incidences rapidly increasing due to improved systemic treatment and cancer patients, survival, the BMs management strategies have evolved substantially from whole brain irradiation to localized multisession SRS. The evolution requires contouring and distributed SRS planning for multiple BMs and treatment followups and has put a high demand on care teams time, efforts, and experience, creating a heavy burden on clinicians. Automated, effective, and efficient tools are unmet clinical needs.